Dissecting CCL5 contribution to antigen specific T cell responses in head and neck cancers

PROJECT SUMMARY
Correlative studies of immune checkpoint blockade (ICB) show that response is highly dependent on the
quantitative and qualitative status of pre-existing antitumor T cell clones. Of particular importance is the reservoir
of tissue resident memory (TRM) T cells that positively correlate with response to ICB therapies. Our work in
head and neck squamous cell carcinomas (HNSCCs) leads us to hypothesize that TRM T cells are major players
in the early anti-tumor immune response to immunotherapy and that identifying specific chemokine and cytokine
networks shaping the development and functionality of antitumor TRM cells will lead to improved therapeutic
strategies. Using scRNASeq and scTCRseq of baseline and on treatment tumor samples from a novel
neoadjuvant anti-PD1 HNSCC clinical trial (NCT02296684), we demonstrated that responding tumors had
clonally expanded putative tumor specific exhausted CD8+ TILs with a TRM program, characterized by high
cytotoxic potential and ZNF683 expression. By contrast, the non-responder baseline tumor microenvironment
(TME) exhibited relative absence of cytotoxic ZNF683+ TILs and accumulation of highly exhausted clones. To
define the determinants of TRM-development, we pursued mechanistic studies using anti-PD1 responsive or
resistant HNSCC cell line syngeneic mouse models. This work confirmed that antitumor TRM-cell activity was
positively correlated with increased frequency and functionality of type 1 conventional dendritic cells (cDC1) and
with enhanced CCL5 chemokine expression in both human HNSCCs and mouse models. To expand our
understanding of TME and tumor draining lymph node specific CCL5 dependent mechanisms underlying
productive or ineffective T cell responses against HNSCC, we will dissect CCL5 driven remodeling of the TME
including defining cellular sources and its target(s). We will extend these studies to human HNSCCs to dissect
CCL5 and CCR5 contributions to DC:T cell interactions in fresh tumor explants. Finally, we will use a therapeutic
approach with a novel oncolytic virus targeted to epidermal growth factor expressing tumor cells that anchors
CCL5 in the TME. Together, this work will address the knowledge gap regarding the factors underlying cytotoxic
versus dysfunctional antitumor tumor infiltrating lymphocytes in the HNSCC TME.

Public health relevance
PROJECT NARRATIVE We aim to advance understanding of the biological determinants shaping productive or ineffective T cell responses within the head and neck squamous cell carcinoma (HNSCC) tumor microenvironment (TME). We have defined a key role for CD8+ tissue resident memory (TRM) T cells in the early anti-PD1 response to HNSCCs and nominated CCL5 chemokine driven remodeling of the TME that promotes antitumor responses. To further dissect CCL5 contribution to CD8+ TRM development, we will use novel mouse models and technologies, human HNSCC samples and a therapeutic oncolytic virus platform to identify approaches to enhance effective antitumor T cell responses.